Tissue Hypoxia and Topical Oxygen Therapy in Ocular Mustard Gas Injury

Mustard gas (MG, most commonly sulfur mustard and nitrogen mustard) is a chemical weapon of mass
destruction and a vesicating agent capable of penetrating mucous membranes. Ocular exposure to MG leads
to eyelid edema, conjunctival injection and chemosis, corneal epithelial defect, opacification, and
neovascularization (NV), limbal stem cell deficiency, and cataract formation, resulting in pain, visual
impairment, and blindness. Despite numerous studies in human and animals, the underlying mechanisms of
MG eye injury are not clear, and to date there is no targeted treatment. Hypoxia and inflammation are
intertwining mechanisms mediating tissue damage after burn including chemical injuries. Tissue hypoxia is an
important mechanism underlying skin and lung tissue damages after MG exposure. In our preliminary study,
we found that ocular alkali burn leads to significant intraocular tissue hypoxia, resulting in the activation of
hypoxia-inducible factor (HIF) signaling, oxidative stress, and inflammation in vivo. In addition, exposure of
human corneal epithelial cells to nitrogen mustard promotes HIF signaling in vitro. However, the role of tissue
hypoxia in ocular MG exposure in vivo has not been studied. We have engineered a perfluorodecalin-based
supersaturated oxygen emulsion (SSOE) as a topical treatment to deliver high levels (over 4 times of
atmospheric levels) of oxygen to the eye. In our preliminary work, we found that a single topical application of
SSOE at time of acute alkali burn drastically reduces intraocular hypoxia and dampens HIF signaling, oxidative
stress, and inflammation. SSOE accelerates corneal epithelial healing and ameliorates corneal opacification,
cataract formation, and tissue fibrosis in vivo. Our overarching goal in this application is to identify the
role of tissue hypoxia and inflammation in MG eye injury and to determine the efficacy of SSOE in
treating MG-related ocular damages. We have established a novel mouse model of ocular nitrogen mustard
exposure and plan to test the following aims: In Specific Aim 1, we hypothesize that tissue hypoxia occurs
rapidly after MG exposure, and we will determine intraocular oxygen levels, HIF signaling, oxidative stress, and
tissue inflammation after ocular nitrogen mustard exposure in vivo; In Specific Aim 2, we hypothesize that
SSOE treatment will reverse tissue hypoxia and reduce inflammation after MG exposure, and will determine
the efficacy of SSOE application in mitigating nitrogen mustard eye injury by assessing tissue hypoxia,
oxidative stress, leukocyte infiltration, tissue fibrosis, corneal opacification/NV, and cataract formation in vivo.
Successful completion of this proposal will not only fill in the knowledge gap in MG injury-related hypoxia
research but provide first proof-of-concept data in demonstrating the therapeutic potential of SSOE as a novel
topical treatment for acute MG exposure. Given that SSOE is formulated to be portable in a small canister and
stable at room temperature, it can potentially be stockpiled and rapidly deployed in a mustard gas attack with
mass casualty and provide countermeasure against chemical threats currently without any treatment options.

Public health relevance
Mustard gas (MG) is a chemical weapon of mass destruction that can lead to blinding disease of the eye and currently has no effective treatment. This grant proposes to study the role of oxygen, particularly the lack of it (hypoxia), in MG-related eye injuries. In addition, this grant will explore the efficacy of a topical oxygen therapy (supersaturated oxygen emulsion) in treating MG eye injury.